Bilingual and Socio-Emotional Development in Dual Language Learners

The U.S. population of dual language learners (DLLs), or children who are exposed to and learning through
two languages, has grown rapidly in the last decade. DLLs from low-income families lag significantly behind
their monolingual English-speaking peers on school readiness measures at kindergarten entry, and the
achievement gap continues to widen with age. Despite the critical role of socio-emotional development (SED)
in children's long-term health and achievement, significant gap exists in our knowledge on how bilingual
experience shapes SED. By integrating the assessment methods on language, executive functions, and SED,
this R01 takes an interdisciplinary approach to study the reciprocal relations between bilingual (English and
heritage language) development and SED in a longitudinal study. We will follow 400 DLLs (50% females,
initially 3-4 years of age) from low-income Spanish-speaking Mexican American families (N = 200) and
Cantonese-speaking Chinese American families (N = 200) annually for three years (T1 and T2 in preschool, T3
in kindergarten). Three waves of multi-method and multi-context data on children's English and heritage
language proficiency, executive functions, SED, and quality of parent-child and teacher-child relationships will
be collected to address the following specific aims: 1) Investigate the contributions of early English and
heritage language development to DLLs' later SED, and test executive functions as a mediating mechanism; 2)
Examine the contributions of early bilingual development to DLLs' parent-child and teacher-child relationships,
and test relationship quality as mediators between language and SED; 3) Examine cultural differences in DLLs'
social relationships, and test whether culture moderates the links between language and relationships; and 4)
Test whether other child, family, and school factors moderate the relations between language and SED. The
proposed research will contribute to the scientific knowledge on the linking of development across domains
(language, executive function, and SED), and have implications for early childhood education policy,
assessment, curriculum development, teacher training, and family engagement practice on DLLs.

Public health relevance
The goal of the study is to examine the bidirectional influences between bilingual (English and heritage language) development and socio-emotional development among dual language learners (DLLs) from low- income Spanish- and Chinese-speaking families. Despite the rapid growth of DLLs in the U.S., the socio- emotional development of young DLLs has been largely ignored. The proposed work will further our understanding of the interconnections among bilingualism, executive functions, and socio-emotional development and could have implications for early childhood education policy, assessment, curriculum, teacher training, and family engagement practice on DLLs.